Administrative Core

The Administrative Core of the Diabetes Research Center at the University of Washington works with the
Center's leadership, committees and staff to oversee the operations of the five biomedical research cores, Pilot
and Feasibility Program and Enrichment Program. The Core is responsible for the following functions that are
integral to the successful functioning of the Center: (1) Overseeing all financial aspects and all personnel
matters; (2) Coordinating and managing the Pilot and Feasibility Program and Enrichment Program; (3)
Managing Center related correspondence and communications, including progress reports to NIDDK and
required information to the University of Washington; (4) Managing the Center's website; (5) Performing
periodic evaluations of ongoing Center activities, functions and services; and (6) Planning future Center
activities, including partnering with centers and organizations at the University of Washington as well as others
that are in and outside Seattle. By performing these functions, the Administrative Core supports the Center in
its primary mission to enhance research, education and training in diabetes, obesity and related disorders at
the University of Washington and in the Greater Seattle area.